Using Common Fund Datasets to Illuminate Drug-Microbial Interactions

PROJECT SUMMARY/ABSTRACT
Each human is, on average, colonized by 1014 microbial cells that mostly reside in the gastrointestinal track.
Research in the last two decades has uncovered the central role of this microbial community in human health
and disease. A pressing challenge, however, is the lack of understanding of microbial drug metabolism.
Experimental studies, clinical observations, and anecdotal examples demonstrate that microbial enzymes alter
drugs through common enzymatic transformations such as reduction, hydrolysis, dehydroxylation,
demethylation, and others. Despite progress, there lacks a systematic approach for the discovery and analysis
for such transformations, thus hindering the design and interpretation of experimental studies. There is therefore
a need to establish workflows to explore such transformations.
We investigate in this proposal microbial drug metabolism at the molecular and community levels. We are
proposing to use data from two Common Fund data sets to conduct this investigation. Illuminating the Druggable
Genome (IDG) catalogues drugs and their pharmacologic action, while the NIH Human Microbiome Project
(HMP) provides detailed gut microbial data for cohorts. We are also proposing to use our deep-learning tools to
predict the likelihood of interaction between microbial enzymes and drugs (Aim 1), and to predict putative
derivative products due to this interaction (Aim 2). Our tools (CSI for Aim 1, and GNN-SOM and PROXIMAL for
Aim 2) have already been validated on other datasets and in other studies, and they will be adapted for microbial
enzymes and drugs based on data culled from IDG and HMP and other resources. The workflows established
in Aims 1 and 2 will be utilized to conduct a pilot study (Aim 3) to investigate the extent of functional redundancy
towards drugs within microbial communities of healthy individuals that are culled from HMP.
The strength of our Approach therefore lies in: i) adapting novel, state-of-the-art deep-learning models to predict
microbial enzyme promiscuity on drugs, ii) providing biochemically explainable drug products, and iii) exploring
how drug microbial metabolism is a function of microbial community composition. The Significance of this
research is that it provides an explainable hypothesis of microbial drug metabolism. The work is impactful as it
will enable further studies, such as exploring the functional redundancy of a microbial community towards drugs
(as planned in Aim 3) and designing and interpreting experimental studies involving the impact of the gut
microbiota on drugs. The proposed work is appropriate for this funding opportunity as it curates and annotates
data using novel deep-learning approaches and creates a previously unexplored link between the HMP and IDG.
1

Public health relevance
PROJECT NARRATIVE The gut microbiota consists of hundreds or more bacterial species harboring millions of genes. There are now documented cases on gut microbes metabolizing common drugs. This research investigates how existing Common Fund Data, from the Illuminating the Druggable Genome (IDG) and the Human Microbiome Project (HMP) databases, can lead to new discoveries regarding microbiota-drug interactions.